US Ten Day Seminar on the Epidemiology and Prevention of Cardiovascular Diseases and Stroke

This proposal requests sponsorship for the US Ten-Day Seminar on the Epidemiology and Prevention of
Cardiovascular Diseases and Stroke. This unique training program includes joint sponsorship from the
National Heart, Lung, and Blood Institute (NHLBI), other interested NIH institutes, the Centers for Disease
Control and Prevention National Association of Chronic Disease Directors, and the American Heart
Association. Given the burden of cardiovascular diseases (CVD) and stroke to this nation, it is highly
appropriate to conduct professional training in research and dissemination of evidence for this topic. The
goals of this proposal are consistent with the goals and objectives outlined in the NHLBI’s Strategic Vision
which seeks to “further develop, diversify, and sustain a scientific workforce capable of accomplishing the
NHLBI’s mission.” Training of such a workforce is a key element of our country’s readiness to address the
health challenges posed by CVD and the readiness to advance multi-component strategies that promote
cardiovascular health (CVH). A prepared workforce will need research competencies in epidemiology and
biostatistics, quality of care, social determinants of health, and policy and environmental approaches to health
promotion and disease prevention. Also, authoritative health agencies and prominent scientists have noted an
increasing need for training professionals to understand methods related to large practical clinical trials,
dissemination and implementation research, and big data analytics. Scientists will also need expertise in cost-
effectiveness research, genetics, environmental health, and biomedical informatics. This Seminar can
uniquely contribute to training scientists who can integrate evidence across all of these fields and translate
research findings into effective and impactful policy and practice.
The following specific actions must be pursued in order to assure the conduct of a successful Seminar:
1. We will continue to attract faculty with both the knowledge of relevant content and the personal teaching
skills required for effective conduct of this program, with a continuing emphasis on recruitment of faculty
from underrepresented racial/ethnic groups (currently 31% of the faculty) and female faculty members
(currently 56% of the faculty);
2. We will continue to adapt program content to maintain its relevance to the training needs of the nation for
health professionals with appropriate career interests, while maintaining a consistent central focus on the
areas described above;
3. We will continue to disseminate information about this program to appropriate target groups, using the
most effective current strategies for reaching underrepresented racial/ethnic groups and female
candidates; and
4. We will continue to broaden the recruitment of participants through past participants, organizations likely to
identify candidates from underrepresented groups (eg, AHA), and other means.

Public health relevance
This proposal requests sponsorship for the US Ten-Day Seminar on the Epidemiology and Prevention of Cardiovascular Diseases (CVD) and Stroke, a unique training program established in 1975, and offered annually since. Given the immense burden of CVD and stroke to this nation in terms of disability, death, disparities, and costs, this focus area is highly appropriate as a setting for professional training in research and dissemination of evidence supporting improved prevention and patient outcomes. Training such a workforce is in line with the NHLBI’s strategic vision, is a key element of our country’s readiness to address the public health and medical challenges posed by CVD, and is critical to advance multi-component strategies that promote cardiovascular health.